Children's Oncology Group Statistics and Data Center

CIBMTR Linkage
COG sites submit clinical data about transplants to the Center for International Blood & Marrow
Transplant Research (CIBMTR). It would be beneficial for COG to have access to the wealth of
patient-level clinical transplant data obtained by the CIBMTR.
ComboMATCH
ComboMATCH will be one of the successor trials to MATCH which will focus on drug
combinations. COG will develop a cassette of treatment sub-studies for pediatric and young adult
patients.
Harmonization and transfer of data to the Pediatric Cancer Data Commons
International pediatric cancer data commons (PCDC) consortiums have been developed for
several disease areas. COG statisticians will harmonize data from completed COG trials to align
with the data dictionaries and then transfer the data to the PCDC.
Molecular Characterization Protocol
The NCI is sponsoring program of centralized molecular characterization for pediatric patients
with brain tumors, soft tissue sarcomas, and selected rare cancers, using Project: EveryChild
(APEC14B1) as the mechanism for enrollment, specimen collection, and clinical annotation.
Molecular Characterization MCI Reporting
The Molecular Characterization Initiative (MCI) provides state-of-the-art molecular
characterization at the time of diagnosis that helps participants and doctors select the best and
most appropriate treatment. Project: EveryChild (APEC14B1) is used as the mechanism for
enrollment, specimen collection, and clinical annotation. MCI data collected via APEC14B1 will
be transferred to the NCI for reporting purposes.
Other Operational Needs
Funds are requested to assist with expenses for Medidata RAVE academic professional
support, Statistical Software, and Supplies for Teleworking Optimization.
Phase III NCNT/NCORP Data Archive
Data from phase 2 and 3 studies completed by COG are available to researchers outside of COG
through the NCTN/NCORP Data Archive. In this grant year data will be submitted to the
NCTN/NCORP Data Archive for manuscripts summarizing results several studies.
Project EveryChild (PEC) Build Optimization
The data collected on Project:EveryChild will be a major source of data for the National Cancer
Institute’s (NCI) Childhood Cancer Data Initiative (CCDI) Global Data Commons. COG has
developed a parent/child study builds plan which would allow for flexibility in form changes and
minimization of the impact of smaller focused child study migrations, greatly reducing the
workload and url resources required for disease specific requested changes.
RAVE Global Library
COG in partnership with Westat has developed processes and procedures to catalogue and
standardize the clinical data within and across COG studies, by disease area, in preparation for
loading into the CCDI Global Data Commons. The standardized data collection will become the
basis for a global library of eCRFs in Medidata Rave which will ensure the usage of the
standards and improve efficiencies in study build and analysis.
Tumor Specimens from Patients at Relapse
COG solid tumor committees have a desire to increase biospecimen banking of tumor tissue
obtained at relapse, with clinical annotation for future research. Funding will be used to
enhance the volume and quality of tumor specimens obtained at relapse, as well as improve the
characterization, stability, and utility of already banked biospecimens.

Public health relevance
The Children’s Oncology Group (COG) is the world’s largest organization devoted exclusively to childhood and adolescent cancer research. Over 220 leading children’s hospitals, universities, and cancer centers across US, Canada and other countries participate in COG research, which is focused on developing better treatments that can improve the cure rate and outcome for all children with cancer.